Application of an Illumina MiSeq i100 Plus System to Strengthen Food Safety and Public Health Surveillance in the Vet-LIRN Network

Project Summary
The Iowa State University Veterinary Diagnostic Laboratory (ISU-VDL), a globally accredited
leader in veterinary diagnostics and One Health innovation, seeks to enhance its Next-Generation
Sequencing (NGS) capabilities through the acquisition of an Illumina MiSeq i100 Plus system.
This critical upgrade will address urgent gaps created by our aging MiSeq instrument (in service
since 2013), which no longer meets the demands of our 20% annual case growth or the evolving
complexity of pathogen surveillance. By modernizing our genomic infrastructure, we aim to
strengthen national food safety, accelerate outbreak response, and advance antimicrobial
resistance (AMR) tracking in alignment with the Veterinary Laboratory Investigation and
Response Network (Vet-LIRN) and One Health priorities.

Public health relevance
Project Narrative The purpose of this proposal is to get support to purchase a new Illumina MiSeq i100 Plus system. Our current Illumina MiSeq sequencer, purchased in 2013, has been in service for over 12 years. While it has been instrumental in our operations, advancing technology and rising demand have outpaced its capabilities. The MiSeq i100 Plus sequencer represents a significant upgrade, offering improved sequencing accuracy (reduced error rates), enhanced throughput capacity, and faster turnaround times. This will significantly enhance our capacity to address critical public health challenges, directly supporting the goals of the Vet-LIRN Network Capacity-Building Project.